Iowa Lung Imaging Training Program

Project Summary/Abstract
The University of Iowa Lung Imaging Training Program will prepare pre-doctoral and post-
doctoral trainees to explore questions related to the respiratory system and lung disease using
medical imaging, image processing, and computational modeling. The program will encourage
trainees to pursue careers related to lung disease research.
Program participants will attain expertise in medical image acquisition, novel imaging hardware,
medical image processing, software development, and computational modeling. Each trainee
will receive individualized attention and assistance with respect to curriculum selection, program
performance and successful completion, and career planning and development. Program
trainees will have access to the extensive resources and facilities that make the University of
Iowa a top-ranked institution in lung health science research, including a number of well-funded
multidisciplinary research programs and graduate education programs such as the Institute for
Clinical and Translational Science Graduate Program in Translational Biomedicine and the Iowa
Institute for Biomedical Imaging.
Program mentors are drawn from 14 different academic and clinical departments across
campus, spanning three different Colleges. The leadership and faculty of this training program
have a notable history of effective collaboration in recruiting, retaining, and training pre-doctoral
and post-doctoral fellows and have a strong interest in developing the next generation of
scientists and engineers with the requisite skills to address urgent problems related to lung
disease.

Public health relevance
Lay Summary Lung disease is a serious health problem and a major cause of morbidity and mortality. We believe that in order to advance our understanding of the lung and respiratory system, we must develop and apply new imaging-based and computational methodologies to help us understand the lung in its normal healthy state and in the presence of disease. In this project, we propose an integrated lung imaging training program to develop the next generation of scientists and engineers prepared to study the normal and diseased lung using medical imaging, image processing, and computational modeling.